TRPC6 inhibition therapy to rescue cardiac muscle dysfunction in muscular dystrophy

Project Summary
This proposal tests the efficacy and mechanisms by which a recently developed, bioavailable, selective small-
molecule inhibitor of Transient Receptor Potential Canonical 6 (TRPC6) ameliorates cardiac and skeletal
myopathy in Duchenne muscular dystrophy (DMD). This research fulfills the candidate’s long-term goals of
advancing novel therapies for dystrophic cardiomyopathy and applying mechanosensitive signaling assays in
mice and engineered heart tissues (EHT) to study disease. DMD results from a loss of dystrophin, inducing
profound progressive muscle weakness, spinal deformities, fibrosis, heart failure, and early mortality. TRPC6 is
a mechanosensitive, non-voltage gated cation channel expressed in muscle cells that is hyper-activated in DMD,
mediating excessive mechanical stress-induced force/Ca2+ responses, arrhythmias, cardiac dysfunction, and
muscle fibrosis. During the candidate’s postdoctoral training, he led projects assessing the impact of blocking
TRPC6 genetically and pharmacologically in models of cardiac fibrosis. Preliminary data in DMD show genetic
or pharmacological TRPC6 inhibition prolongs lifespan in severe DMD models by 2-3 fold, ameliorating fibrosis
and associated pathology, and improving heart and skeletal muscle function. The candidate first reported on the
TRPC6 drug inhibitor (BI 749327) in 2019, and its clinical derivatives are now in human trials for lung and renal
disease. In this proposal, the candidate addresses key questions whose answers will importantly inform future
DMD translational efforts, and is organized into three aims. Aim 1 tests the efficacy of chronic TRPC6 inhibition
by BI 749327 to prevent and reverse DMD skeletal and cardiac muscle dysfunction, histopathology, and TRPC6-
NFAT, pro-fibrotic, and inflammatory signaling. Cell-type expression is analyzed by single-cell RNAseq to identify
how subpopulations of cardiac cells that express TRPC6 (fibroblasts, vascular, and myocytes) are impacted by
the treatment. Aim 2 tests the capacity of chronic TRPC6 suppression to restore mechanical activation-induced
defects in force and calcium in isolated DMD mouse cardiomyocytes, and to obviate effects of membrane
sealants and other mechanosensitive-activated pathways. I will further test the role of TRPC6 pathobiology in a
novel human DMD EHT model of mechanosensitive activation using the same mechanical stimuli as in mouse
cardiomyocytes. Aim 3 tests the efficacy of micro-dystrophin (μDys) gene therapy to treat TRPC6 pathobiology
in the recently-developed D2.mdx DMD mouse model or the combination of μDys with BI 749327 provides
additive benefits. The proposal uniquely combines the candidate’s prior training with expertise from his mentors.
The candidate has the unique skills needed to conduct these studies, combining biomedical engineering, muscle
physiology, and molecular signaling experience. He will expand into single-cell transcriptomics, stem cell derived
EHT and their mechanical analysis, and DMD gene therapy. The environment at Johns Hopkins and expert
mentoring team provides every opportunity for success for the candidate and project.

Public health relevance
Project Narrative This project identified a potent and clinically-relevant target, Transient Receptor Potential – Canonical 6 (TRPC6), that is hyperactivated in Duchenne muscular dystrophy (DMD) and contributes to heart disease. The proposed research will test 1) the only known TRPC6-inhibiting drug in three mouse models of DMD and 2) newly-developed engineered heart tissue platform that can simultaneously assess mechanical stress responses in human engineered heart tissue from Duchenne muscular dystrophy stem cell lines and 3) a new combination of TRPC6 inhibition and micro-dystrophin gene therapy in DMD mice. The results from this study are of clinical importance, because 1) TRPC6 inhibition may be a complementary treatment for all muscular dystrophy patients, 2) novel engineered heart tissue testing platforms will allow the testing of mechanical stress signaling and 3) TRPC6 inhibition may provide additive benefits when combined with micro-dystrophin therapies – both of which are currently in human clinical trials.